Regulatory Role of Mitochondrial DNA in Bladder Cancer Progression

ABSTRACT
Bladder cancer (BCa) is a common solid tumor and exhibits poor outcomes when regionally advanced or
metastatic. Only modest improvements are seen even with aggressive surgical or medical treatments. Most
patients with advanced cancer ultimately succumb to their disease with the most significant prognostic factor
being the presence of metastasis. While much work has been done on identifying the presence of metastatic
tumor cells in lymph nodes, little research currently explores the mechanisms that govern BCa progression to a
metastatic phenotype. It is now well recognized that genetic factors, intrinsic to the primary tumor, and
microenvironmental factors, independent of the primary tumor are involved in metastatic progression. One key
understudied regulator of metastatic efficiency may be mitochondrial DNA (mtDNA). Variations in mitochondrial
copy number and loss of mtDNA have been implicated as pathogenic events in BCa, and changes in mtDNA
have been measured in patient samples; however, little is understood about the functional contribution of mtDNA
to metastatic progression due to lack of suitable and available laboratory models. We have developed a model
to determine contributions of mtDNA, designated MNX – mitochondrial-nuclear exchange. Transgenic mice are
generated with matched nuclear DNA but different mtDNA from separate strains such that maternal inheritance
determines mtDNA content in constant nuclear backgrounds. Prior studies from the Welch lab (mPI) using these
mice in breast and melanoma models indicate mtDNA is a novel metastasis efficiency regulator. Moreover,
mtDNA changes in the microenvironment independent of the tumor itself may further regulate the potential for
metastasis. However, no such studies have been done in genetically credentialed models that accurately
recapitulate human disease. Our preliminary data indicates that transfer of C3H/HeN mtDNA into a C57Bl/6J
nuclear background results in more rapid tumor progression, especially in female mice. We hypothesize that
specifically altering mitochondrial genetics will fundamentally alter tumor progression and metastasis
rates in BCa via signaling changes in both tumor cells and the tumor stroma. We will use the highly
credentialed N-butyl-N-(4-hydroxybutyl) nitrosamine (BBN) induced BCa model in murine strains with different
rates of tumor formation (C3H/HeN and C57BL/6J) to investigate this hypothesis. In Specific Aim 1, we will
evaluate the role of mtDNA in primary BCa tumor progression to metastasis using WT and MNX mice. In Specific
Aim 2, we will determine the contribution of cellular and stromal elements to BCa metastasis in WT and MNX
mice. These studies will define the role of mtDNA in this model and lead to future experiments understanding
how loss or gain of mtDNA specifically effects both murine laboratory models and patients.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Bladder cancer (BCa) is a common solid tumor with poor outcomes in advanced disease with the most significant prognostic factor being the presence of metastasis. While much work has been done on identifying the presence of metastatic tumor cells in lymph nodes, little research currently explores the mechanisms that govern BCa progression to metastasis. These studies will define the role of mitochondrial DNA in BCa metastasis and open an entirely new area of development for biomarkers, therapeutics, and targeted preventative medicine.